Cell specific Partitioning Defective Par1a/b deletion effects on renal repair

Abstract
We will study the role of serine threonine kinases Partitioning defective (Par) 1a and 1b in
adaptive and maladaptive repair following tubular injury. In studies by our laboratory of the
developing kidney, dual loss of Par1a and 1b impaired Notch activation: this demonstrated for
the first time a link between Par1 and Notch signaling. We hypothesize: Par1a/b kinases are
activated in proliferating progenitor cells by kidney injury and regulate Jag1-Notch dependent
and independent pro-fibrotic pathways. Using inducible cell specific deletion of both Par1a/b in
mice, we will test effect of Par1a/b on Notch activation and progenitor cells following injury. We
will investigate the mechanisms underlying the novel Par1-Notch link. Our specific aims are: 1)
Show that Par1a/b regulates the response to kidney tubule injury via the Notch pathway; and 2)
Demonstrate that Par1a/b in tubular progenitor cells promotes maladaptive repair.

Public health relevance
Project Narrative Chronic kidney disease is common and causes serious complications – including loss of kidney function. With a goal to protect against loss of function, the proposed studies will investigate a new potential therapeutic target – Par1 signaling. The mechanisms to be examined may also be important in kidney repair after acute kidney injury.